Embryonic Emergence of Heterochromatin and Nuclear Supervision of Mitochondrial Genetics

Project Summary/Abstract
We will address two fundamental aspects of biology in Drosophila. The first involves the mechanisms
regulating the onset of differentiation of a naïve embryonic genome. Developmental time resolves progressive
steps that introduce the specialized domains of chromatin structure. We found that the molecular hallmarks of
heterochromatin emerge late, after heterochromatic behaviors that the marks were thought to specify. We will
explore the mechanisms establishing the earlier specializations of heterochromatin domains. Clustered arrays
of repeated sequences (satellites) become late replicating in the 14th cell cycle prior to histone methylation
(H3K9me) and heterochromatin protein 1 (HP1) binding. We found that regulated recruitment of Rif1, a
replication inhibitor, explains developmental onset of late replication, and that a temporal schedule of its
dissociation directs a temporal program of sequential replication of the satellites. We will use powerful in vivo
tools to understand how time is programmed. But what targets Rif1 to satellite sequences? We found that the
satellite sequences are compacted even earlier, prior to Rif1 recruitment, but then what is the basis of
compaction? Repetitiveness is the universal distinguishing feature of satellite sequences. Recently, our
neighbor Sy Redding and the Rosen lab showed that in vitro assembled chromatin with nucleosomes
periodically positioned on repetitive sequences autonomously condenses into a liquid-like phase. In
collaboration with Sy Redding we will relate the simple physical observations and in vivo behavior of satellite
repeats. The approaches taken here will define the progression of interactions that evolution selected to guide
the initial formation of distinct genomic subdivisions that underlie much of complex metazoan biology.
The second project examines the genetic independence of the mitochondrial (mt) genome. Despite its
bacterial origins, the mt genome is viewed as well adapted; however, an independently transmitted genetic
element always has a renegade option. It is cooperative only as long as it is advantageous. The distinct
genetics of the multicopied maternally transmitted mt genome is usually learned as uncomplicated, but this is
belied by complexities in the transmission of disease mutations and age dependent onset of phenotypes.
Inadequate genetic tools have hidden important features of mt genome behaviors that we have accessed with
new tools. We show that the ability of a mutant mt genome to compete with the pool of other genomes in a cell
determines its fate. The nuclear genome manipulates this inter-mt genome competition to give beneficial
outcomes, but fragile points in this nuclear management allow successful transmission of some mutant
genomes and underlie an age-associated decline in mt genome integrity. We propose experiments that will
dissect the basis of nuclear management of the mt genome. Identifying modulating nuclear activities will
enhance predictability of mt disease severity and introduce new avenues for their therapeutic management.

Public health relevance
Project Narrative Our analysis of the emergence of heterochromatin will advance understanding of epigenetic programming, disruptions of which contribute to cancer and developmental abnormalities. Our studies of mitochondrial genetics probe mechanisms of inheritance of mitochondrial diseases and degenerative changes with aging. These mitochondrial studies might uncover targets for interventions that would block propagation or accumulation of pathogenic mitochondrial mutations.